Dissecting mechanisms of anthracycline-induced cardiotoxicity

ABSTRACT
While cancer affects more than one in three people over their lifetime, improved long-term survival has led to an
increase in the incidence of adverse cardiac side-effects of cancer treatments. Anthracyclines such as
doxorubicin (Dox) are a cornerstone of chemotherapy in various cancers, however, their use is complicated by
anthracycline-induced cardiotoxicity, most commonly cardiomyopathy. The mechanisms at play in Dox
cardiotoxicity are multifactorial and include Topoisomerase (Top)-2β-mediated DNA damage that may culminate
in apoptosis. To identify novel actors in the disease process, we first conducted a comprehensive search in
biomedical databases of Dox cardiotoxicity transcriptomic studies. Candidate genes were screened for
responsiveness to Dox treatment, association with the Notch and Hippo pathways implicated in cardiac repair,
and the control of cell death. This systematic approach led to the identification of serine incorporator-3 (serinc-
3). W
e hypothesize that in the setting of Dox-induced cardiotoxicity, serinc-3 exhibits protective effects by
opposing Top-2β-mediated cardiomyocyte apoptosis that we will explore in 2 Specific Aims
. In Aim 1, we will
determine the role of serinc-3 in Dox injury in cardiomyocytes and cancer cells. We will (i) dissect the protective
role of serinc-3 on apoptosis pathways implicated in Dox cardiotoxicity, (ii) determine an association between
serinc-3 and the cardioprotective Notch and Hippo pathways in cardiomyocytes, and (iii) perform transcriptome
sequencing and quantification, gene network construction, and determine biochemical and functional pathway
enrichment in Dox treatment following serinc-3 expression modulation, (iv) establish protein interactions with
serinc-3 using a 3xFLAG tagging strategy, co-immunoprecipitation, and mass spectrometry, and (v) evaluate
serinc-3 expression in breast cancer and lymphoma cells, and quantify cancer cell proliferation following Dox
treatment and serinc-3 modulation. In Aim 2, we will scrutinize in vivo serinc-3 function in cardiomyocytes
following adult mouse Dox treatment. We will (i) develop tamoxifen-inducible, cardiomyocyte-specific Cre-Lox
mice with enhanced green fluorescent protein for successful serinc-3 Cre excision, (ii) quantify global (ejection
fraction, fractional shortening) and segmental (strain, displacement) cardiac function following serinc-3 Cre-Lox
knockdown or adeno-associated virus-9-mediated overexpression in the setting of chronic Dox injury, (iii) assess
the effect of serinc-3 overexpression and knockdown on Dox-induced cell death pathways in vivo, and (iv) isolate
cardiomyocytes from Dox treated mice to establish correlation matrices by transcriptome sequencing following
modulation of serinc-3 expression. The successful implementation of the proposed research will provide novel
mechanistic insights into the pathobiology of anthracycline-induced cardiotoxicity, with translational implications.

Public health relevance
PROJECT NARRATIVE – RELEVANCE TO PUBLIC HEALTH Anthracyclines such as doxorubicin are among the most potent chemotherapies and form the backbone of regimens used to treat multiple adult and pediatric cancers. Their use however is hampered by the frequent development of injury to the heart, leading to heart pump failure and ensuing complications. The proposed research will address the protective effect of serinc-3 on the heart injury process caused by doxorubicin.